Role of Membrane Dynamics In Cell Surface Glycan Recognition

PROJECT SUMMARY
Lectin-glycan interactions play an essential role in a wide range of physiological and pathological processes.
Most lectins bind to glycans via multivalent interactions, in which multiple binding domains in a single lectin
simultaneously interact with multiple glycan molecules. Lectins are pattern recognition molecules that recognize
a spectrum of glycan ligands. The interplay between spatial organization of glycans and lectins adds a delicate
approach to control cellular processes. Because glycans attached to lipids or membrane proteins can diffuse on
the two-dimensional cell membrane, changes in membrane dynamics can modulate glycan patterns, leading to
alternation in lectin activities. Understanding the molecular basis of the lectin-glycan recognition principle will
help to predict cellular processes. In the first research area, the PI plans to investigate how spatial organization
of glycan ligands influences glycobiology processes on the cell membrane. Probing lectin-glycan interactions on
the cell surface is challenging, due to the inherent complexity of the cell membrane. The techniques in
microscopy and spectroscopy will be combined with multiscale computational modeling to unravel microscopic
binding mechanisms. This integrated approach offers a feedback loop allowing not only the refinement of the
simulation model using experimental data, but also theoretical predictions to guide the experimental designs. In
addition, the PI will explore innovative approaches to control cellular processes by manipulating local glycan
patterns via membrane perturbation. The influence of drugs, nutrition, and cell polarity on lectin activities will be
investigated. The knowledge will catalyze therapeutic advancements to combat glycan-associated diseases. In
the second area, analytical approaches that can directly monitor glycan patterns on cells will be developed.
Alternation in glycan patterns is highly dynamic and can be affected by cell environments and growth conditions.
Frequent monitoring glycan patterns is critical to elucidating lectin functions and predicting biological
consequences. However, the lack of effective glycan analysis tools delays the development of glycobiology
research. The PI will integrate vibrational microscopy and machine learning algorithms to profile glycans on
glycoproteins and cells. The success will provide a rapid and accessible sensing platform for the scientific
community to conduct glycan analysis at single-cell level.

Public health relevance
PROJECT NARRATIVE Spatial organization of glycans can regulate glycobiology processes. Understanding the influence of membrane dynamics on glycan pattern is critical to predicting biological consequences and controlling cellular processes. This project aims to unravel the glycan recognition principle on the cell membrane as well as develop accessible sensing platforms for glycan pattern analysis.